Chemical approaches toward the identification, functional analysis, and biosynthesis of small molecule cyclomodulins

PROJECT SUMMARY/ABSTRACT.
Bacteria on and within the body (the microbiota) influence human physiology, therapeutic responses, and disease states. Cyclomodulins are bacterial toxins and effectors that modulate eukaryotic cell cycle progression,
proliferation, differentiation, or apoptosis, and may be genotoxic. Certain strains of E. coli in the human gut
contain a gene cluster (referred to as “clb”) that encodes small molecule cyclomodulins known as precolibactins. Evidence suggests precolibactins are prodrugs that are converted to cytotoxins (colibactins) by a dedicated peptidase (colibactin peptidase, ClbP). clb+ E. coli induce DNA double-strand breaks in mammalian cells
in vitro and in vivo, suggesting these molecules are trafficked (by an unknown mechanism) to eukaryotic cells,
and initiate tumor formation in colitis-susceptible mice treated with azoxymethane. Several independent studies have demonstrated that the clb cluster is epidemiologically correlated with colorectal cancer in humans. As
colibactins are unstable, all isolation efforts have employed clbP deletion strains to facilitate accumulation of
the more stable precolibactins. We developed convergent high-yielding syntheses of linear precolibactin biosynthetic precursors and showed they transform to unsaturated imines after ClbP deacylation; these imines
alkylate DNA by nucleotide addition to an electrophilic cyclopropane. Structure–function studies established
distinct DNA recognition and prodrug domains. Of equal significance, our data indicate that the use of clbP
deletion strains results in the production of alternative, non-genotoxic structures, such as precolibactins A–C.
Precolibactin-886 is the most complex clb isolate known and is the first that contains an α-aminomalonate residue, which is believed to be important for cytopathic effects. We hypothesize that the unusual macrocyclic
structure of precolibactin-886 also derives from employment of a clbP deletion strain. To test this we will prepare precolibactin-886 and key synthetic derivatives/biosynthetic precursors and elucidate their chemistry. We
will determine if deacylation of the linear precursor to precolibactin-886 leads to production of similar electrophilic imines. We will evaluate the potency, cell cycle effects, and DNA-damaging abilities of synthetic colibactins and controls in a zebrafish model. Using enzymology, genetic deletion studies, and X-ray crystallography,
we will elucidate the roles of the enzymes ClbL, ClbO, ClbM and ClbS, which are encoded in the clb cluster but
do not have well-defined functional roles. The latter two enzymes phenotypically contribute to colibactin resistance and their study may illuminate methods to inhibit clb+ E. coli-associated colorectal cancer. This grant
employs four investigators with non-overlapping expertise in chemical synthesis, natural products biosynthesis
and isolation, preclinical studies of clb+ E. coli in vitro and in vivo, and enzymology and protein crystallography.
This work will establish a mechanistic model that accounts for all known precolibactins, define the molecular
mechanisms by which certain E. coli induce carcinogenesis, and inform strategies to inhibit clb+ E. coli-driven
tumorigenesis. These studies will provide insights into the functional roles of non-proteiogenic cyclomodulins.

Public health relevance
PROJECT NARRATIVE. Select strains of Escherichia coli in the human gut produce small molecules known as precolibactins, which are precursors to tumorigenic colibactins. This grant presents a plan to synthesize and study the most advanced (pre)colibactins in vitro and in vivo, and to elucidate the molecular mechanisms by which these E. coli drive tumor formation. This work may ultimately illuminate new therapeutic strategies to inhibit bacteria-associated colorectal cancers.